Advanced Fibrosis Detection and a Predictive Diagnostic Model for Metabolic Dysfunction-associated Steatotic Liver Disease (MASLD) in Primary Care

Abstract
Advanced Fibrosis Detection and a Predictive Diagnostic Model for Metabolic Dysfunction-associated
Steatotic Liver Disease (MASLD) in Primary Care. Metabolic dysfunction-associated steatotic liver disease
(MASLD, formerly nonalcoholic fatty liver disease [NAFLD]) affects an estimated 1 in 3 persons in the U.S., a
prevalence expected to increase over the next decade. MASLD’s rising prevalence and its association with
diabetes and obesity make it a chronic disease well-suited for initial management by primary care providers
(PCPs). PCPs can impact MASLD care by detecting advanced fibrosis, which is the best predictor of cirrhosis,
hepatocellular carcinoma, and liver-related mortality in affected patients. Recently issued guidelines from the
American Association for the Study of Liver Diseases recommend the sequential use of non-invasive liver tests,
the Fibrosis-4 Index (FIB-4) followed by confirmatory liver stiffness measurement (LSM) with vibration-controlled
elastography (VCTE), to detect advanced fibrosis in patients with MASLD. FIB-4 is attractive in primary care due
to the low-cost and broad availability of its inputs, but PCPs have little experience with FIB-4 calculation, limited
comfort with its interpretation, and infrequent access to confirmatory liver stiffness testing. The guidelines provide
a clinical threshold for hepatology engagement, recommending referral for patients with advanced fibrosis, while
those with low-risk MASLD remain in primary care. Incorporating advanced fibrosis detection into the already
overwhelming workload of PCPs requires thoughtful application of electronic health record (EHR) technologies
to avoid contributing to PCP alert fatigue and burnout. Also, despite the high prevalence, MASLD is
underdiagnosed in primary care due to a host of factors that include the lack of recommendations for universal
screening and limitations in the performance of traditional MASLD signals for case finding, including type 2
diabetes mellitus, obesity, and abnormal liver chemistries. Iterative efforts to address the MASLD diagnostic care
gap need to assist PCPs in identifying which patients need liver imaging and ensure that the signals for diagnostic
testing capture MASLD with advance fibrosis, disease PCPs cannot miss. In this work, we aim to test the
adoption, penetration, fidelity, sustainability, and performance of a novel, non-interruptive EHR alert for MASLD
fibrosis risk assessment in a primary care network by performing a stepped wedge, cluster randomized trial in
patients with known MASLD (Aim 1). We will also develop, test, and internally validate a predictive diagnostic
model for identifying MASLD and MASLD with advanced fibrosis in a prospective cohort of patients with no
known chronic liver disease (Aim 2). This proposal aligns with NIDDK’s scientific goal to disseminate, implement,
and evaluate evidence-based care strategies in community care settings where the burden of MASLD hides in
plain sight.

Public health relevance
Project Narrative This proposal evaluates the implementation of a novel, non-interruptive, electronic health record alert for metabolic dysfunction-associated steatotic liver disease (MASLD) fibrosis risk assessment in primary care patients with known MASLD using a stepped wedge, cluster randomized design. To address MASLD underdiagnosis in primary care, this study will also develop, test, and internally validate a predictive diagnostic model for MASLD in a prospective cohort of patients with no known chronic liver disease. This work will generate generalizable data to dramatically enhance MASLD diagnosis and management in primary care.